Virginia Cancer Screening Research Network Access Hub (Virginia CSRN Hub)

This application is being submitted in response to the NOSI identified as NOT-CA-24-111. This Administrative
Supplement will expand recruitment from 1600 patients to 2000 patients as requested by National Cancer
Institute (NCI) and address the newly identified costs of workup for positive multi-cancer detection tests
(MCDs). Efforts will occur in the Virginia Hub for the National Cancer Screening Research Network (CSRN), a
national network capable of conducting clinical trials and longitudinal studies, a central Statistics and Data
Management Center, and a central Coordinating and Communication Center. Our Virginia CSRN ACCESS
Hub was created from long-standing, inter-institutional partnerships to assist in this important national effort.
These partnerships include 1) three health systems – Virginia Commonwealth University (VCU) Health, Inova
Health System, and Sentara Healthcare; 2) one medical school – VCU; 3) two cancer centers – the Massey
Comprehensive Cancer Center at VCU, an NCI-designated comprehensive cancer center, and the Inova
Health’s Schar Cancer Institute which includes a recently launched Saville Cancer Screening and Prevention
Center; 4) the NIH-funded Wright Regional Center for Clinical and Translational Science; and 5) a state-wide,
primary care practice-based research network (Virginia Ambulatory Care Outcomes Research Network –
ACORN). These entities have an established track record of working together for decades; collectively care for
a sizable proportion of state residents including the largest safety net health system providing both urban and
rural services to a majority of Virginia’s communities; demonstrated expertise in recruiting and retaining
marginalized and underserved patients and communities in trials; and national expertise in cancer prevention,
informatics, community engagement, and dissemination and implementation science. We proposed that the
Virginia CSRN ACCESS Hub would initially recruit and retain at least 1,600 participants in the NCI-
coordinated, three-arm randomized controlled Vanguard study to test two novel multi- cancer detection (MCD)
tests compared to usual cancer screening care. NCI has requested this to be expanded to 2,000 participants.
We will measure success by equitable and inclusive recruitment, timeliness and adherence to the diagnostic
workup and treatment protocols, and participation in all national CSRN efforts. Additionally, we will conduct a
novel, mixed methods analysis of our work using a consolidated framework for implementation research
constructures to demonstrate our hub’s feasibility and sustainability for future CSRN trials and to assess
factors necessary for widespread adoption of MCD tests, if proven effective. Our hub will meaningfully
contribute to the Vanguard study and will bring unique partnerships, an equity lens, and dissemination and
implementation expertise to the broader CSRN effort.

Public health relevance
PROJECT NARRATIVE The National Cancer Institute (NCI) is creating a Cancer Screening Research Network (CSRN) to conduct national randomized controlled trials and longitudinal studies to evaluate new technologies for cancer screening and close critical evidence gaps. To assist in this effort, we propose to create the Virginia CSRN Accrual, Enrollment, and Screening Sites (ACCESS) Hub from long-standing inter-institutional partnerships between three health system, one medical school, two cancer centers including an NCI-designated comprehensive cancer center, an NIH-funded clinical and translational science center, and a 500+-practice primary care practice-based research network. The Virginia CSRN ACCESS Hub will participate in the proposed Vanguard study – a randomized controlled trial of multi-cancer detection tests – and demonstrate its distinct ability to recruit and retain inclusive and diverse participants onto national cancer screening trials and evaluate factors necessary to broadly disseminate and implement new cancer screening practices.